Update of the WTC Cancer Tissue Biobank

Immediately after the 9/11 terrorist attack, concerns were raised about the short and long term effects of exposure
to the World Trade Center (WTC) dust cloud. Responders and residents were exposed to a complex mixture of
toxic chemicals that included multiple known and suspected human carcinogens which could increase cancer risk.
Over the years, an increased risk in overall cancer incidence, and specifically of prostate, thyroid, melanoma and
tonsil cancers has been observed. To understand the biological reasons for the observed cancer increase, in 2015
we established at MSSM the cancer tissue biobank (CTB), with CDC/NIOHS support. Currently 472 tumor tissue
samples from responders have been collected, characterized and stored. Research on the cancer samples have
significantly moved forward the field; for prostate, our own study on cancer tissues suggests the possibility of a
biologically more aggressive cancer due to the nature of the environmental exposure in this population. Several
ongoing collaborative studies involve tissue biomarkers of tumor behavior, aggressiveness, as well as whole
genome analyses on cancer and normal adjacent tissues to understand if WTC exposure played a role in cancer
etiology and outcome. We propose to update the existing biobank of human solid organ tissues from each
cancer diagnosed after 2018, the date of last follow-up, among the WTC rescue and recovery workers, and
to link the existing biobank to BioMe, an electronic medical record-linked blood biobank at MSSM of all
patients' encounters who signed a research consent. The scope is to create an overall picture of the WTC
responder's health, including clinical data and blood samples pre-cancer diagnosis, to facilitate future clinical and
translational studies on WTC cancer etiology, biology, and cancer outcome.
This project proposes to update the central repository of cancer tissue samples and adjacent normal tissue from
each solid cancer diagnosed among the WTC Health Program (WTCHP) participants. This repository has the
capability to be linked with the main WTCHP data set containing clinical, epidemiological and exposure information,
as well as with the peripheral blood sample collected from the participants at the time of inclusion in the WTCHP.
Through BioMe we will also access complete medical record history, and blood samples collected before or after
a cancer diagnosis for WTC responders with cancer who are also MSSM patients. Clinical information collected
by BioMe, and ancestry, will be available as well. Adding blood to the WTC cancer sample biobank will open the
possibility of studies on temporal changes in systemic inflammation, metal and other toxicant exposure,
metabolomics, and other biological markers over time. Blood-based markers can also be compared against
markers observed in cancer tissue samples. We establish the tissue bank as a resource for the science community,
by defining a process for qualified applicants to request available samples for research use, and for linking with
the epidemiologic and clinical information in the database. A plan for the evaluation of the tissue bank usage and
success, as measured by publications and funding obtained by investigators using the samples, is also included.

Public health relevance
We address the increase cancer incidence among the World Trade Center (WTC) responders by updating the WTC tissue bank system with the newly diagnosed cancers (after 2018), and to link the tissue bank with Biome to access complete medical record history, and blood samples collected before or after a cancer diagnosis for WTC cancers who are also MSSM patients. PUBLIC HEALTH RELEVANCE: The biobank will represent the necessary infrastructure for addressing questions such as the link between specific carcinogens exposures and certain cancer sites, molecular signatures of exposure that could be linked to cancer, specific markers of tumor aggressiveness among WTC responders.